Neurobiology of Sensory Preconditioning

Summary
Learning and memory storage is a complex process that has proven challenging to tackle. Despite significant
progress in understanding classical conditioning, it is likely that in nature, the instructive value of reinforcing
experiences is acquired rather than innate. In other words, many of our learning experiences occur by inferring
value from a previously associative structure of the environment and not by the mere contiguity of conditioned
and unconditioned. This is relevant because the association between seemingly neutral stimuli expands the
gamut of possibilities to create meaningful associations and generalizations and increases the predictive power
of moment-by-moment experiences. High-order conditioning falls within this category of learning. This proposal
aims to understand the biological basis of olfactory sensory preconditioning, a form of high-order
conditioning. Specifically, we will use behavioral and functional imaging techniques combined with neuronal
and genetic manipulations, including optogenetics, to define the basic rules and dynamics of sensory
preconditioning. We will also test the dopamine modulation’s role in this form of learning. Finally, we will test the
hypothesis that olfactory representations are altered during sensory preconditioning and that this altered
representation is fundamental for forming associations between valueless stimuli. The long-term goal of this
proposal is to gain knowledge on the biological basis of how our brain achieves sensory
preconditioning.
This proposal is highly significant because there is a big gap in our knowledge of biological basis of high-order
conditioning. In addition, understanding how memories are encoded and disrupted in brain disorders is a
prerequisite to the rational design of treatments for memory impairment. Our understanding of memory formation
is based heavily on classical conditioning research. Nevertheless, we argue that high-order conditioning is
more relevant than Pavlovian association in real naturalistic situations. The results of the present studies
will provide guideposts for future research into the neurobiology of memory formation during high-order
conditioning. The project will support our long-term goal of understanding memory down to the single-cell and
subcellular levels, contributing to the knowledge base necessary for the rational development of novel treatments
for memory impairment.

Public health relevance
Narrative Memory impairment is a core deficit accompanying many neurological disorders. This proposal will examine how a simple nervous system encodes model-based memories constructed on inferred values (sensory preconditioning). These experiments will add to the knowledge base required for the rational design of treatment for memory disorders.